OADDL Testing Support for CVM Vet-LIRN-2

Abstract - OADDL Testing Support for CVM Vet-LIRN (PI-Akhilesh Ramachandran)
The aim of this proposal is to seek funding for Oklahoma Animal Disease Diagnostic Laboratory (OADDL
to support critical CVM Vet-LIRN (Veterinary Laboratory Investigation and Response Network)
surveillance and diagnosticprograms. Services within our capabilities will be offered to test clinical
samples, animal food/feed/drug samples, environmental samples related to animal food/feed/drug. In
addition we will also offer animal diagnostic necropsy services as needed. OADDL is a full service
diagnostic laboratory founded in 1976 and has maintained continuous accreditation with the American
Association of Veterinary Laboratory Diagnosticians (AAVLD) since 1978. OADDL has the necessary
expertise, infrastructure and cutting edge technology to provide tremendous benefit to CVM Vet-LIRN
critical projects.

Public health relevance
Project Narrative - OADDL Testing Support for CVM Vet-LIRN (PI-Akhilesh Ramachandran) Oklahoma Animal Disease Diagnostic Laboratory (OADDL) will offer its expertise and services to participate in critical disease testing and surveillance projects initiated by the Food and Drug Administration (FDA), Center for Veterinary Medicine (CVM) Office of Research Veterinary Laboratory Investigation and Response Network (Vet-LIRN). OADDL has been providing critical support to CVM Vet- LIRN for the past 5 years assisting with necessary testing needs and OADDL has also played a significant role in the collection of select bacterial pathogens for surveillance of antimicrobial resistance surveillance. The current proposal seeks funds to maintain OADDL’s current support to Vet-LIRN and continue to be actively involved in the missions of Vet-LIRN.